Previvors Recharge: A Resilience Program for Cancer Previvors

It is estimated that approximately 5-10% of all diagnosed cancers are caused by Hereditary Cancer
Syndromes (HCS) that are associated with germline mutations (inherited genetic mutations passed directly
from a parent to a child that create a genetic predisposition to certain types of cancer). Recent epidemiologic
models indicate that 1 in 279 people may be carriers of one of the most common HCS, and advances in genetic
testing continue to identify new inherited mutations. Individuals with an HCS (Previvors) have up to an 80%
lifetime risk of developing cancer and are at an increased risk of developing multiple primary cancers during
their lifetime, often with onset at an early age. Previvors face multiple forms of adversity, including a multitude
of annual cancer screenings and the uncertainty of not only their own health but the health of affected family
members. Previvors also regularly experience “scanxiety” while anticipating, undergoing, and awaiting the
results of screenings. While interventions to promote resilience among Previvors would address an important
unmet public health need, existing solutions have a number of gaps that limit effectiveness, widespread
dissemination, and applicability to Previvors.
The proposed research will employ a participatory design approach to create and examine the
acceptability and preliminary effects of PREcharge, a resilience-boosting solution specifically designed for
Previvors and delivered primarily via bi-directional text messaging. PREcharge will use proven approaches to
behavior change tailoring to increase resilience by promoting a positive mindset, strong social connections, and
a deep sense of meaning and purpose while also proactively addressing scanxiety. The design and development
of PREcharge will be informed by extensive and ongoing end-user input from 10 Previvor advisors as well as 6
experts in this area. One hundred and twenty-nine Previvors will be recruited for a 30-day pilot test. Phase I
milestones will include: 1) acceptability of the program, as evidenced by overall mean ratings of at least 4 out of
5 on a widely used acceptability measure and obtaining 75% endorsement that users would recommend the
program to a fellow Previvor; (2) engagement as evidenced by continued receipt of text messages and one or
more interactions with the online tools by at least 70% of participants; and (3) benefit from the program,
evidenced by statistically significant pre-post improvement on the Connor Davidson Resilience Scale. Pilot
participants who fail to sustain engagement will be asked to provide feedback on how PREcharge could be
improved. The data from this pilot test will lay the foundation for the further development of tailored text-
messaging solutions to improve resilience outcomes among the expanding population of Previvors. This type of
easily disseminable, potentially cost-effective, and highly tailored solution would overcome the limitations of
existing interventions and provide a framework for messaging on other key behaviors (e.g., health care
provider communication) in the future.

Public health relevance
8. Project Narrative For the estimated one out of every 300 Americans who have a Hereditary Cancer Syndrome but have not yet been diagnosed with cancer (Previvor), adversity often comes disguised as a multitude of cancer screenings a year and the uncertainty of the health of family members. The proposed research will develop and evaluate a prototype of PREcharge, an interactive program designed to increase resilience among Previvors by administering brief assessments and using multivariate algorithms and proven approaches to behavior change tailoring to provide timely, individually tailored text messages to promote a positive mindset, strong social connections, and a deep sense of meaning and purpose while also proactively addressing scanxiety through online tools. This program has the potential to improve the psychological health of a growing population of individuals navigating the uncertainty and emotional toll of Hereditary Cancer Syndromes.